Health Behavior, Communication, and Outreach Core

The main goals ofthe Health Behavior, Communication and Outreach Core are to: Provide support for SCC investigators incorporating epidemiological, psychological, and health education methods in their research. Assist SCC investigators in reaching minority and underserved populations, addressing their needs, and evaluating approaches to reducing inequalities in cancer prevention and care. Facilitate development of Prevention & Control Research Program and its collaboration with Clinical & Translational, Oncologic Imaging and Basic Research Programs of the SCC Research Training.

Public health relevance
The Health Behavior, Communication and Outreach Core provides services to investigators engaged in Prevention and Control and Clinical/Translational research. The Core has played a role In the SCC initiative to identify and address disparities in minority access to clinical and population-based research, providing services not otherwise available to researchers.